Strengthening the Master of Health Research Ethics Training Program

PROJECT SUMMARY
In order to ensure more expertise in research ethics to support the rapid increase in research activities
taking place in Malaysia, the Master of Health Research Ethics (MOHRE) program at Universiti Malaya
(UM) was developed in collaboration with the Johns Hopkins Berman Institute of Bioethics (JHU). This
regionally first of its kind health research ethics degree program has now been fully implemented and
accredited and has produced 17 trainees with an additional 8 trainees who will be graduating this year. The
overall goal of our application, Strengthening the Master of Health Research Ethics Training Program, is to
strengthen the MOHRE program and ensure its sustainability by: (1) developing and implementing a more
flexible training program that includes full-time and part-time enrolment options; (2) strengthening the
program guided by a novel, empirically derived research ethics competency framework developed by our
program (FRESCO: Framework for Research Ethics Studies Competencies and Outcomes) and
systematically embedding context-appropriate cases in the curriculum; and (3) enhancing UM faculty’s
capacity in research ethics education and scholarship. Since its inception, the program has sparked interest
among working professionals in bioethics-related fields in Malaysia and the region. However, its current
format is not ideal for professional students who prefer part-time study, course schedules that occur outside
of usual working hours, and more online learning opportunities, which are now in very high-demand due in-
part to the COVID-19 pandemic. With a new format, the program will further produce 26 trainees (21
Malaysians; 5 from regional low- and middle-income countries). We aim to utilise FRESCO and an
eCasebook collated based on regionally relevant cases to further strengthen the program. Finally, we will
conduct a robust faculty development program which will include an annual faculty development workshop
and a structured mentoring program to equip UM faculty members with necessary knowledge and skills to
lead the MOHRE program in the future. In sum, the proposed measures will facilitate our team to expand
health research ethics expertise in Malaysia and other low- and middle-income countries in Southeast Asia.
Eventually, we aspire to establish a regional research ethics network that will include MOHRE alumni as
leaders making meaningful contributions towards the design and conduct of ethically sound health
research.

Public health relevance
PROJECT NARRATIVE To meet the need for increasing research ethics capacity in Malaysia and Southeast Asia, in partnership with collaborators from the Berman Institute of Bioethics at Johns Hopkins University, this initiative aims to enhance the leading-edge Master of Health Research Ethics (MOHRE) program at Universiti Malaya (UM). Program enhancements will include increasing program flexibility to increase enrolment of working individuals positioned to make meaningful contributions to research ethics, strengthening the program by using a newly articulated competency framework, and implementing a robust UM faculty development program. By the end of the project period, the MOHRE program will be more sustainable and be positioned to help meet local and regional needs in research ethics.